Resource Core

PROJECT SUMMARY/ABSTRACT – Resource
The mouse has long served the scientific community as the mammalian model of choice for the study of
human disease. Decades of work used mice to great success in the study of single gene mutations to
better understand human biology and monogenic disorders. This compendium of work greatly advanced
our understanding of gene function, but it was also long recognized that the genetics of human health
was more complex than could be revealed by studying single genes in isolation. Fortunately, specialized
mouse strains were developed to begin to dissect more complex genetics and as the “omics” age
emerged the mouse was developed into an even more powerful model for the study of genetics at the
“systems” level. Strains have been developed, and more are under development, which have “human-
like” genetic diversity. These strains, and their predecessors, provide an experimental avenue to
modeling genetic complexity with an accuracy and confidence that allow findings to be translated to the
clinic more rapidly.
Over the years, a number of valuable resources have been created to study complex genetics. These
resources range from inbred strains, hybrid mapping panels, classic Recombinant Inbred (RI) lines, and
Chromosome Substitution (CS) strains, all the way to more recent strains such as the highly diverse
Collaborative Cross (CC) and Diversity Outbred (DO) populations. The utility of these special mouse
strains is entirely dependent upon getting consistently high-quality mice into the hands of researchers
around the world.
The Special Mouse Strains Resource (SMSR) at The Jackson Laboratory (JAX) has provided reliable, efficient
access to these specialized strain panels for the scientific community and ensured their perpetuation though
cryopreservation. The SMSR is unique in its ability to provide high health status facilities with streamlined
order management and short delivery times. As importantly, the SMSR continues, to work closely with the
complex trait community to evolve its resources and to provide access to large-scale mouse breeding and
housing capacity to support collaborative research projects.
The SMSR will continue to provide this high-quality resource through the following aims: Aim 1 - SMSR will
actively distribute as well as archive specialized mouse strains and related resources for complex trait analysis.
Aim 2 - SMSR will maintain complete and accessible strain information and informatics resources for SMSR
strains. Aim 3 - SMSR will evaluate new and existing resource needs.